Vascular and neural mechanisms of chronic lower leg heating in pregnant women with obesity

PROJECT SUMMARY/ABSTRACT
Obesity is a major risk factor for hypertensive disorders of pregnancy (HDP). The underlying mechanisms are
largely unclear, but maternal vascular endothelial dysfunction is likely involved. Endothelial dysfunction in HDP
could be attributed to 1) alterations in the L-arginine/nitric oxide (NO) pathway, and 2) an increase in endothelin-
1 (ET-1). Additionally, augmented sympathetic vasoconstriction may also contribute to HDP. Chronic (repeated)
whole-body heat exposure has been shown to increase NO bioavailability, decrease ET-1, and cause functional
and structural adaptations in the vasculature. All these can improve vascular function, attenuate sympathetic
(re)activity, lower blood pressure (BP), and reduce cardiovascular risk in non-pregnant individuals. Whether this
is also true after regional (lower leg) heating in high-risk pregnant women is unknown. Our central hypothesis is
that chronic lower leg heating will be effective in improving vascular endothelial function and attenuating
sympathetic vasoconstriction, leading to a reduction of the risk for HDP in pregnant women with obesity. The
overarching goal of this proposal is to determine the vascular and neural effects of chronic lower leg heating in
obese pregnancy. We plan to enroll 118 pregnant women with obesity between 12-14 weeks of gestation and
randomly assign them to either an intervention group or a control group (1:1 ratio). Participants in the intervention
group will perform 16 weeks of home-based lower leg heating via water immersion up to the knee in a circulated
bath (water 42°C, 4 times/week, 45 min/session), whereas those in the control group will immerse their legs in a
thermoneutral water bath (33°C) at the same frequency and duration. Participants will be evaluated at baseline
and then at 28-30 weeks of gestation. Aim 1 will determine the effects of chronic lower leg heating on maternal
vascular function and surrogate markers of HDP. We will measure brachial artery flow-mediated dilation and
placental perfusion (ultrasound). Blood samples will be collected for the estimation of NO (via nitrate and nitrite
analysis), L-arginine, asymmetric dimethylarginine, 3-nitrotyrosine, and ET-1. Angiogenic factors, in combination
with ambulatory BP, will be used as surrogate markers of HDP. Aim 2 will determine the effects of chronic lower
leg heating on sympathetic vasoconstriction and BP. We will measure sympathetic activity (microneurography),
leg vascular conductance, and neurovascular transduction. Sympathetic reactivity will be assessed during a
graded upright tilt. We will also measure 24-h ambulatory BP. The relationship between sympathetic (re)activity
and BP will be evaluated. Finally, we will determine the association between changes in sympathetic
vasoconstriction and endothelial function after intervention. Findings from this project will provide insight on the
extent and potential mechanisms of how chronic lower leg heating works for improving vascular endothelial
function and sympathetic vasoconstriction in pregnant women with obesity. Results obtained will set a foundation
for future large multicenter clinical trials to determine the efficacy and generalizability of home-based lower leg
heat therapy as a safe, ease-of-use, cost-effective, and non-drug approach for reducing the risk of HDP.

Public health relevance
PROJECT NARRATIVE Women with obesity are 2-3 times more likely to have complicated pregnancies and to die from cardiovascular diseases during pregnancy compared to women with normal weight, while vascular endothelial dysfunction and excessive sympathetic vasoconstriction may be responsible for the poor health and adverse birth outcomes in obese women. Through this study, we aim to determine whether home-based chronic (repeated) lower leg heating can improve vascular function and reduce sympathetic vasoconstriction in pregnant women with obesity. Results and knowledge obtained from this study may give direction to developing non-drug preventive and/or treatment options for high-risk pregnant women in the future.